Therapies for Age-Related Macular Degeneration

Choroidal neovascularization (CNV) represents the most common cause of severe vision loss in patients with age-related macular degeneration (AMD). It is also the most common cause of legal blindness in the United States in patients over the age of 60. Therefore, the study of the diagnosis, prevention and treatment of this condition would have a major impact on the public health. The laboratory is heavily involved in drug development for the treatment of neovascular AMD. These efforts are within the realm of drug delivery and drug formulation development. Within drug delivery, the laboratory is focusing on the use of sustained implant technology. One important aspect of this work is focusing on the ability of drugs to cross the scleral and allow for extraocular placement of these devices. Published work has reported on our observations that physiologic rather than physical barriers appear to limit drug penetration into the eye. Using a gadolinium implant, work in both alive and dead rabbits showed a dramatic difference in ocular drug penetration highlighting the importance of these physiologic barriers. In a further extension of this work in rabbits, various techniques to alter these physiologic barriers including cryotherapy to reduce choroidal blood flow and removal of conjunctival tissue to alter choroidal vascular and lymphatic elimination routes demonstrated the importance of these physiologic barriers. On-going work is focused on a more precise identification and manipulation of these barriers. Focusing on the need for improvements in anti-angiogenic agents and modes of delivery, work is continuing on the sustained drug delivery of two integrin antagonists, EMD 0587 and a short peptide, C16Y, both of which have been shown in the laboratory to have anti-angiogenic effects in a laser-induced model of CNV.